Diversity among plastic synapses: Defining pathway specific eTrace competence in reinforced cortical learning

Project Summary
Reinforcement learning is a highly successful framework that guides learning through reward and
punishment. Standard Hebbian plasticity cannot account for how animals learn through delayed reinforcement
as reward/punishment received after a behavior must specifically modify relevant synapses which were active
seconds to minutes before. A theoretical solution to this discrepancy suggests the generation of transient synaptic
tags, referred to as eligibility traces (eTraces), which decay after neural activity. The theory further posits that
such transient and “silent” eTraces are then converted to express synaptic plasticity upon release of chemical
neuromodulators conveying reward information. The first experimental demonstration of cortical eTraces by the
Kirkwood lab was in the visual cortex, at the feedforward layer 4 → layer 2/3 connection, where neuromodulators
acting through G-protein coupled receptors (GPCRs) anchored at the postsynaptic density (PSD) convert eTraces
into synaptic plasticity. Recently, the Kirkwood lab found that neuromodulator effects are restricted to L4 →
L2/3 synapses and are not effective at L2/3 → L2/3 inputs. In this application, I aim to test the hypothesis that
eTraces are pathway specific even within a single postsynaptic neuron. Furthermore, I hypothesize that GPCRs
involved in converting eTraces are differentially expressed at postsynaptic compartments to define which
pathways are competent for eTrace-mediated synaptic plasticity. I aim to test the hypothesis, using
electrophysiology, that within a single layer 2/3 pyramidal cell eTraces are restricted to the feedforward pathway
(Aim I). Additionally, I will investigate the presence of eTrace-specific GPCRs at each of these pathways to
confirm my prediction for a molecular definition of eTrace competence (Aim II). Lastly, I will test the predictions
of input-specific eTraces using several models of in vivo plasticity, which produce bidirectional plasticity specific
to the layer 4 → layer 2/3 and/or the layer 2/3 → layer 2/3 pathways. Results from this work will molecularly
define reinforcement competent synapses and show that these are a subset of all plastic synapses, demonstrating
previously undescribed synaptic diversity that is relevant for fully understanding how neural circuits learn.
Finally, this knowledge may allow the development of methods to transplant reinforcement learning with the
goal of facilitating functional recovery and learning in defined regions of the brain.

Public health relevance
Project Narrative Organisms learn quickly and effectively when guided by reward and punishment, but the neural basis of such reward-based learning is not fully understood. The proposed work will examine the cellular and molecular basis of a reinforcement-like learning mechanism. Results from this work could allow development of interventions that can enhance or limit reward-based learning mechanisms to benefit treatment of learning disorders or abnormal reward-based learning as seen in addiction.